Role of spleen educated monocytes in mediating ischemia-reperfusion injury followinglung transplant surgery

Extremely high rates (>50%) of primary graft dysfunction (PGD) due to ischemia reperfusion injury (IRI) are the
predominant cause of impaired post-lung transplant outcomes resulting in both short-term mortality as well as
chronic lung allograft rejection. PGD is driven by the recruitment of neutrophils into the allograft which, upon
extravasation into the alveolar space, undergo NETosis to cause irreversible lung injury. We and others have
found that depleting neutrophils can ameliorate PGD but is not clinically feasible given their importance in
pathogen clearance. Accordingly, in the prior funding period, we focused on understanding the mechanisms that
drive neutrophil trafficking to the lung following transplantation. Our work facilitated the discovery of a fascinating
multicellular signaling pathway that underlies PGD: A) donor-origin Ly6ClowCCR2- non-classical monocytes
(NCM) retained in donor lungs release neutrophil chemokine CXCL12 to recruit recipient neutrophils, B) bone-
marrow derived recipient Ly6ChighCCR2+ classical monocytes (CM) stored in the spleen are mobilized to the
allograft through donor NCM-dependent activation of donor alveolar macrophages (AM), C) upon entry into the
allograft, the CM permeabilize the pulmonary endothelium through IL-1β dependent downregulation of zona
occludens-2 and tight junction protein Claudin-5 to enable extravasation of recipient neutrophils. Experiments
performed in the prior cycle and additional preliminary data further suggested that the CM are activated through
toll receptor signaling (TLR) and the release of IL-1β is NLRP3 inflammasome dependent. Excitingly, our data
uncovers a novel function of the spleen in priming bone marrow derived CM to activate the NLRP3 inflammasome.
Single cell transcriptomics and high resolution spatial intravital imaging indicated that the splenic metallophilic
macrophages released TGF- to recruit CM to the spleen independent of CCR2-CCL2 axis while the red pulp
macrophages primed them release IL-1β through the activation of NLRP3 inflammasome, a process that required
3 days. These data fundamentally change the understanding of the spleen from a monocyte reservoir into an
active immune organ necessary for a coordinated response to injury. Collectively, our data strongly support the
hypothesis that after lung transplantation, IL-1 released by spleen-primed CM recruited to the lung is
dependent on TLR signaling and activation of NLRP3 inflammasome. We will test our hypothesis using two
aims: Aim 1. Determine the mechanisms of activation of CM after migration from spleen to the transplanted lung.
Aim 2. Determine if spleen functions as both a reservoir and site for monocyte priming to mediate lung allograft
injury. Our experimental design takes advantage of our models of sequential spleen and lung transplantation as
well as state-of-the-art techniques such as spatial intravital imaging and single cell/spatial transcriptomics. We
will use complementary genetic and pharmacological techniques to perform causal experiments to prove our
hypothesis while creating a rich molecular atlas of human ischemia reperfusion injury. These studies will facilitate
the rapid translation of our findings to clinical practice.

Public health relevance
Extremely high rates (>50%) of primary graft dysfunction (PGD) due to ischemia reperfusion injury (IRI) are the predominant cause of impaired post-lung transplant outcomes resulting in both short-term mortality as well as chronic lung allograft rejection. In the prior funding cycle, we developed state-of-the-art research tools and complex murine models of sequential spleen and lung transplantation to unravel a fascinating multicellular signaling complex led by recipient classical monocytes primed in the spleen that was responsible for the pathogenesis of PGD. In the next funding cycle, we will use complementary genetic and pharmacological techniques to identify the mechanisms through which classical monocytes are activated after reaching the transplanted lung as well as those that result in the recruitment and priming of classical monocytes in the spleen while generating a molecular atlas of PGD to facilitate rapid clinical translation.